Genomic and Microenvironment Analysis of HIV-Associated Diffuse Large B-cell Lymphoma (Immuno/Microenvironment)

PROJECT SUMMARY/ABSTRACT
This proposal addresses the high priority statement related to “HIV-associated comorbidities, coinfections, and
complications.” This study will be addressing this high priority requirement from two aspects, including the study
of co-infection by EBV and HIV, as well as the molecular differences between EBV+ and EBV- diffuse large B-
cell lymphoma in HIV+ patients.
HIV-associated diffuse large B-cell lymphoma (HIV+/DLBCL) remains an understudied disease and is one of the
leading causes of death in persons living with HIV on anti-retroviral therapy. Although there have been significant
strides taken with de novo DLBCL in terms of molecular classification, HIV+/DLBCL has lagged behind,
particularly because it was originally excluded from most large studies. While approximately 30% of these tumors
can be EBV-positive, potentially serving as a driving mechanism for lymphomagenesis, the molecular
pathogenesis in the majority of cases have not been comprehensively studied. Additionally, the tumor
microenvironment (TME) plays an important role in lymphomas related to prognosis and therapy, but this area
has not been investigated in HIV+/DLBCL. We hypothesize that by investigating the genomic landscape and
TME of HIV+/DLBCL, we will identify key cellular vulnerabilities and pathways that can provide insights for
tailoring novel therapies for patients with HIV+/EBV-positive versus HIV+/EBV-negative DLBCL. Utilizing our
multi-institutional collaboration, we plan to evaluate the 1) whole “omics” of HIV+/DLBCL as well as 2) investigate
the TME of HIV+/DLBCL using multispectral immunofluorescence in conjunction with spatial gene expression
data, EBV-status, and genomic data. 3) We will utilize the Lymphoma and Leukemia Molecular Profiling Project
(LLMPP) with their established pathology review and bioinformatics pipeline to facilitate this study which will
generate important data that we and other investigators around the world can use in future years to generate
new hypothesis, design targeted treatments and trials for this aggressive disease.

Public health relevance
PROJECT NARRATIVE Diffuse large B-cell lymphoma (DLBCL) is an aggressive subtype of non-Hodgkin lymphoma and is one of the leading causes of death in persons living with HIV despite anti-retroviral therapy. The genomics and tumor interaction with nearby inflammatory cells is not well studied in HIV-associated DLBCL (HIV+/DLBCL) but is important for the understanding, management, and treatment of this deadly disease. We will conduct an extensive genomic and spatial analysis of this tumor in persons living with HIV disease to better understand the vulnerabilities which can be targeted in future therapeutic trails of HIV+/DLBCL.